The Molecular Basis for Myosin-10 Regulation

PROJECT SUMMARY/ABSTRACT
A critical function for all living organisms is the ability to move when needed. These movements–intracellular
trafficking, cell division, muscle contraction, and cell motility–are driven by molecular machines that exert an
amazing amount of force considering that they are only a few nanometers across. Given the variety of motor
proteins in the cell, a key question is how motors cooperate and compete while moving cargoes and applying
forces. An emerging paradigm is the notion of specialized motors, or motors that are fine-tuned to perform a
specific function. Despite the importance of these motor proteins, relatively little is known about their individual
adaptations and how these relate to the motility patterns found in the cell. This work focuses on myosin-10 and
its unique ability to navigate to a specific location in the cell. Myosin-10 delivers essential cargoes such as
integrins, cadherins and netrin receptors to filopodia at the leading edge of the cell. This transport function plays
a pivotal role in migrating cells, both in normal developmental biology and in metastasizing tumor cells. To
navigate the cell, myosin-10 walks along multiple filaments in the fascin-actin bundle found at the core of the
filopodium, and effectively ignores other actin filaments in the rest of the cell. The proposed work will study how
ligand binding, myosin quaternary structure, and actin filament architecture all tune myosin-10 motility. The
approach will integrate structural biology techniques applied to full-length myosin-10, coupled with a
comprehensive and systematic investigation of the ligands that lead to full activation and processive motility.
This proposal will test the hypothesis that myosin-10 is regulated by head-to-tail autoinhibitory interactions that
are relieved by phosphorylation and, potentially, cargo binding. Completion of this study will yield a molecular
mechanism for cytoskeletal motor protein navigation in the cell. It will further define the general principles that
determine how all types of cytoskeletal motors engage cargo, activate, and navigate. Motor protein activation
and navigation is a process of fundamental biological importance but is poorly understood. This work will direct
future efforts to understand and control motility in multiple contexts.

Public health relevance
Project Narrative Motile cells use the motor activity of myosin-10 to transport and organize and their contents, and is critical for proper development of higher animals. We will use advanced single-molecule and structural biology methods to determine how myosin-10 is activated and generate force within the cell. This work will allow us to address critical questions about cell mechanics, including how cancer cells migrate and colonize new sites in the body.